Administrative Core

ABSTRACT
The purpose of the Administrative Core is to support the translational research objectives of the MSKCC
SPORE in Leukemia by serving as the organizational center, optimizing collaboration among SPORE
investigators within and outside MSKCC. The specific aims of the Administrative Core are (1) to provide
effective organization, management, and coordination for all educational, clinical, and scientific activities; (2) to
provide comprehensive centralized administrative and financial support to all the components of the SPORE:
research projects, cores, CRP and DEP as well as interactions with EAB and IAB; and, (3) To foster effective
communication with all key stake-holders, both intramural and extramural, including the broader scientific
community, cross-institutional collaborators, the NCI, our patient advocate(s) and the general public. The
Administration Core will be led by Omar Abdel-Wahab, MD, who will oversee all SPORE activities. The
Administrative Core also includes personnel trained in financial management, project management, grants
administration, scientific and medical editing, data management, and administrative support. The capabilities
and services centralized in the Administrative Core provide the following administrative and communications
infrastructure that serve all components of the SPORE:
· Scientific Oversight: monitor progress of the translational research objectives of the SPORE program,
including evaluating the progress of individual projects and making decisions regarding
continuation/replacement projects
· Financial Management: serving as the centralized SPORE budgetary coordinator and financial manager
· Editorial Services: providing editorial services for manuscript publication and grants coordination
· Grants Administration: serve as administrative liaison to the National Cancer Institute, ensuring the timely
submission of all required reports and compliance with institutional and federal regulations
· Data Management System Support: assist relevant Cores in management and support of SPORE related
research and clinical databases as well as maintaining a cohesive and functional data sharing plan
· Communication: foster communication and collaborative research within our SPORE as well as with
other SPOREs in Leukemia and the wider scientific community
· Outreach: foster effective communication with the general public, our patient advocate(s) and, the
broader patient community to ensure that SPORE clinical studies are patient-centered and to
promote equitable access to treatment on SPORE studies
· Meetings Coordination: organize all SPORE related retreats and meetings and review of ongoing
SPORE research projects, cores, and pilot projects as well as the solicitation of new pilot project

Public health relevance
PROJECT NARRATIVE The Administrative Core provides centralized scientific, managerial, and administrative oversight of the SPORE in Leukemia at Memorial Sloan Kettering Cancer Center. The core will leverage institutional resources and coordinate institutional interactions as well as administrative, fiscal, regulatory, and data management activities to facilitate efficient achievement of the translational research objectives.